Investigating CREB5-driven mechanisms of immune therapy resistance

Project Summary:
Treatment with immune checkpoint inhibitors induce remarkable clinical responses in several cancer types.
However, most cancer patients do not respond to immunotherapy, and patients who initially respond often exhibit
acquired resistance. Understanding the universe of immune evasion strategies will enable the design of more
effective immunotherapies. In preliminary studies, we identified genes that drive immune evasion by performing
a genome scale in vivo CRISPR gain-of-function screen in tumors treated with anti-PD-1 antibodies; and
discovered the transcription factor CREB5 as a top resistance mediator. We found CREB5 overexpressing
tumors exhibit poor responses to anti-PD-1 and have fewer infiltrating CD8+ T cells. Using transcriptional
profiling, we showed CREB5 drives upregulation of extracellular matrix genes including collagen and collagen-
stabilizing factors. Collagen is the major ligand for the inhibitory receptor LAIR1, which is broadly expressed on
T cells, B cells, NK cells, and myeloid cells. Deletion of LAIR1 in mice or overexpression of the decoy receptor
LAIR2 in tumors abrogates the resistance-causing effect of CREB5 overexpression, suggesting that CREB5
overexpression drives resistance via collagen-LAIR1 inhibitory signaling. These observations form the
foundation of our proposed studies to decipher the role of this tumor intrinsic mechanism of resistance to immune
checkpoint therapy. Specifically, we propose to understand: 1) the molecular mechanisms governing CREB5
regulation and transcription; 2) CREB5-interacting proteins that drive collagen matrix deposition; and 3) the
mechanism(s) by which LAIR1-collagen sensing inhibits anti-tumor immune responses. These studies will not
only advance our understanding of immune regulation but will also provide new insights and targets useful for
the development of new immunotherapy approaches for cancer.

Public health relevance
Project Narrative: Immune checkpoint inhibitors sometimes induce dramatic tumor responses. Despite clear clinical benefit, a minority of tumors respond to immunotherapy, and many tumors become resistant to therapy. We have identified a tumor-intrinsic pathway induced by the transcription factor CREB5 that modulates tumor immunity through alterations in collagen expression and deposition. In this project, we propose to decipher the mechanisms that regulate CREB5 expression in tumors and to interrogate the role of collagen in regulating immune cells. These studies will provide insights into immune cell regulation by the extracellular matrix and provide a foundation to identify and develop new targets for immune therapy of cancer.